NFkB during TLR signaling in macrophages

DESCRIPTION (provided by applicant): Inflammatory signaling by macrophages in response to pathogens or tissue injury is the key determinant of the pathology and pathogenesis of infectious and non- infectious disease. Signaling is initiated by Toll-like receptors (TLRs) and results in complex gene expression programs. The transcription factor NFκB controls the inflammatory portion of the program, and understanding its regulation in response to TLR signaling is the goal of this project. During the previous funding period, we have used combined experimental / computational modeling approach to gain a predictive understanding of NFκB in response to specific IκB kinase (IKK) activity profiles, and in response to the cytokine TNF and ribotoxic stress agents. However, preliminary results suggest that TLR signaling cannot be accounted for by a single kinase input into the NFκB signaling module, but that multiple regulatory mechanisms converge to regulate NFκB. Here we will undertake quantitative experimental studies in conjunction with computational modeling to produce a predictive understanding of the regulation of the key inflammatory regulator NFκB and its associated gene expression programs in response to a variety of TLR agonists. Three specific aims focus on specific mechanisms that critically modulate NFκB activity in macrophages in response to specific input signals; the fourth aim integrates these to produce a comprehensive predictive model of TLR signaling to NFκB. We will demonstrate its utility as a research tool and will provide it to the broader community. PUBLIC HEALTH RELEVANCE: Inflammatory signaling by macrophages in response to pathogens or tissue injury is the key determinant of the pathology and pathogenesis of infectious and non- infectious disease. Here we will undertake quantitative experimental studies in conjunction with computational modeling to produce a predictive understanding and predictive research tool of the regulatory mechanisms controlling inflammatory responses.

Public health relevance
Project Narrative Inflammatory signaling by macrophages in response to pathogens or tissue injury is the key determinant of the pathology and pathogenesis of infectious and non- infectious disease. Here we will undertake quantitative experimental studies in conjunction with computational modeling to produce a predictive understanding and predictive research tool of the regulatory mechanisms controlling inflammatory responses.